HYPOCHLOREMIA IN A MEDICAL INTENSIVE CARE UNIT

The purpose of this study is (1) to determine the incidence and prevalence of hypochloremia in MICU patients receiving long-term enteral feedings with standard feeding regimens. (2) To determine the incidence & prevalence of metabolic alkalosis associated with hypochloremia in MICU patients receiving long-term enteral feedings. (3) To determine whether hypochloremia associated with long-term enteral feedings develops in patients who do not have excessive chloride losses from enteral or renal sources.